THREE REGIMENS OF GANCICLOVIR IN HIV PTS WITH VARYING DEGREES OF RENAL FUNCTION

The purpose of this study is to describe the pharmacokinetics of oral ganciclovir in HIV positive subjects with varying degrees of renal functional impairment. A secondary objective is to compare the dose proportionality of three regimens in patients with normal renal function.